Exposure to Ambient Air Pollution and Temperature During Spermatogenesis: Impact on Men's Reproductive Health and Infertility Treatment Outcomes

PROJECT SUMMARY/ABSTRACT
Approximately 12% of couples in the United States seek infertility treatment, which for some is associated with
treatment-related side-effects, treatment-related stressors, and a significant financial burden. Although male-
factor infertility contributes to an estimated 30-50% of cases of couple infertility, risk factors, mechanisms, and
potential interventions for male-factor infertility have been critically understudied. Ambient air pollution and
ambient temperature extremes are ubiquitous exposures associated with systemic inflammation and oxidative
stress, to which the process of spermatogenesis may be uniquely susceptible. Research has found exposure
to high levels of air pollution may adversely impact semen quality; however, the effect of exposure during
developmentally-sensitive windows of spermatogenesis on semen quality, impacts on sperm epigenetic factors
including DNA methylation, and the cumulative impact of male partner exposure on infertility treatment
outcomes have been little evaluated. This study will utilize data from the Folic Acid and Zinc Supplementation
Trial (FAZST) to estimate impacts of ambient environmental factors on male fertility, adding estimates of
individual exposure to ambient air pollution and temperature. Adding to sparse literature from countries with
low-to-moderate levels of air pollution, this study will evaluate exposure to air pollution and high and low
ambient temperatures during developmentally susceptible windows of spermatogenesis (mitosis, meiosis,
spermiogenesis, and spermiation) with semen quality, leveraging four repeated semen samples from more
than 1,900 participants (Aim 1). Epigenetic alterations in sperm are increasingly recognized as a potential
mechanism impacting male fertility, with exposure to several oxidative stress-inducing and endocrine-
disrupting environmental factors linked to differential DNA methylation in sperm. This study will conduct a novel
assessment of the impact of ambient air pollution exposure on sperm DNA methylation (Aim 2). Finally, this
study will utilize information on outcomes of infertility treatment cycles (in vitro fertilization and intrauterine
insemination cycles) and timing of treatment-related semen samples to evaluate the impact of male partner
exposure to air pollution and ambient temperature during spermatogenesis on probability of pregnancy during
infertility treatment, accounting for exposure windows during embryogenesis and implantation (Aim 3). This
career development award will extend the candidate’s prior training and research experience in environmental
and reproductive epidemiology by providing expert mentoring and targeted training in epigenetics, air quality
exposure assessment, and causal inference. Her primary mentor Dr. Richard Pilsner (epigenetics), along with
members of her mentoring team Dr. Timothy Canty (air quality modeling) and Dr. Laura Balzer (causal
inference), with provide the needed mentoring for the candidate to establish a productive independent research
program. In addition to targeted training, this K01 award will add novel evidence for the impact of ambient air
pollution and temperature on men’s reproductive health and outcomes of infertility treatment.

Public health relevance
PROJECT NARRATIVE Men’s reproductive health is a critically understudied area of research, and ambient exposures including air pollution and temperature may have important adverse impacts on male fertility. Together, findings from this study will provide a comprehensive understanding of the impact of exposure to ambient air pollution and both high and low ambient temperatures during developmentally-relevant windows of spermatogenesis on men’s reproductive health and infertility treatment outcomes. Findings will add to the evidence base identifying optimal timing of infertility treatment to male partner environmental risk factors and suggesting future research directions for potential benefits of behavioral or pharmacologic interventions in the weeks leading up to fertility treatment.